Identifying new targets for the treatment of alcohol dependence and relapse: epigenetic analysis of the abstinent brain

SUMMARY
Alcohol use disorder (AUD) affects more than 12% of the US population and is the fourth leading preventable
cause of death in the US. AUD is associated with compulsive drinking and emergence of a negative emotional
state during abstinence, resulting in two-thirds of afflicted people relapsing within months of completing alcohol
cessation treatment. Repeated cycles of intoxication and abstinence are linked to persistent alterations in the
brain that remain long after detoxification, which drive relapse of drinking, often at levels higher than before
abstinence. Identifying the molecular mechanisms that lead to hazardous alcohol use and contribute to the high
rates of relapse is imperative for the effective design of better treatments to curb alcohol abuse. Our previous
studies illustrate the power of integrating epigenetic, transcriptomic, circuitry, pharmacology and behavioral tools
to elucidate the molecular underpinnings contributing to hazardous alcohol use. Those studies, using genome-
wide DNA methylation (DNAm) analysis of the nucleus accumbens (NAc) to compare macaque alcohol-naive
and alcohol-drinkers, identified differential DNAm (D-DNAm) signals, mapping to genes not previously linked to
alcohol use, but with high relevance to synaptic plasticity modulation. Experimental manipulation of two of these
DNAm-linked genes resulted in altered glutamate and GABA neurotransmission and changes in ethanol intake.
The the next critical step is to understand how repeated abstinence/relapse cycles alters DNAm signals and how
these changes contribute to adaptations in neurocircuitry. We hypothesize that some D-DNAm signals
associated with chronic alcohol use may persist during abstinence, contributing to risk of relapse. In addition, de
novo D-DNAm signals generated during repeated cycles of abstinence/relapse, may further heighten relapse
risk. To identify abstinence-associated DNAm, we will use the highly translational macaque alcohol self-
administration model and our proven genome-wide approach to identify D-DNAm in the NAc of macaques
following > 12 months of chronic alcohol self-administration and then 3 cycles of forced abstinence (each cycle:
1 month abstinence and 3 months of open-access). After integrating gene and transcript variant expression and
D-DNAm data generated from the same subjects and tissues, a subset of compelling, novel targets will be
selected for functional study using pharmacological and genetic manipulation approaches in a mouse chronic
intermittent ethanol (CIE) model. This rodent CIE model has been extensively used to model cycles of alcohol
exposure and withdrawal leading to an escalation of drinking during relapse. In addition to recording ethanol
intake, the effects of target manipulation on neurotransmission will be evaluated using patch-clamp
electrophysiological analysis. Overall, these studies will aid in our understanding of the molecular mechanism(s)
establishing risk for relapse. This information will be critical to advancing the development of effective therapies
for alcohol abuse and to prevent relapse.

Public health relevance
NARRATIVE This study investigates the epigenetic mechanisms orchestrating the enduring alcohol-induced neuroadaptations of the brain following repeated cycles of abstinence/relapse. A combination of epigenetic, transcriptomic, pharmacological, gene editing and behavioral strategies will identify novel genes and pathways that hold promise as potential new therapeutic targets to curb alcohol abuse and prevent relapse.